Mitochondrial DNA Compaction and the Accumulation of Mutations with Age and Stress

PROJECT SUMMARY/ABSTRACT
The primary goal of this project is to understand the impact of mitochondrial genome architecture on the
accumulation of somatic mitochondrial DNA (mtDNA) mutations, which build up over an individual’s lifetime due
to ongoing replication and oxidative stress. Because these mutations can cause or exacerbate cellular aging,
this work has implications for the prevention and treatment of age-related degenerative diseases. The study will
utilize innovative long-read sequencing approaches to quantify accessibility, mutations, and various types of
damage all along individual mtDNA molecules. Mechanistic work in cultured human cells will quantify the role of
mtDNA compaction in protection against mutations from various pharmacological, genetic, and environmental
stressors as well as define the temporal dynamics of mtDNA architecture at single molecule resolution. Work in
vivo will seek to define the consistency of mtDNA form across cell type and age. Together, these approaches
will offer a comprehensive understanding of how mtDNA compaction influences mutation rates and mitochondrial
health, potentially unveiling new avenues for therapeutic intervention to mitigate aging and related diseases.

Public health relevance
PROJECT NARRATIVE Mitochondrial DNA accumulates mutations over the course of an individual’s lifetime that can cause or exacerbate age-related diseases. This project seeks to gain a greater understanding of the role that mitochondrial genome architecture plays in protecting cells from the oxidative and replicative stress that can lead to mutations. In the long term, this work may uncover new therapeutic targets that could be used to reduce the impact of age-related degenerative diseases.